EFFECTS OF COCAINE WITHDRAWAL AND CRAVING ON CEREBRAL ACTIVITY MEASURED BY MRI

The overall goal of this study is to determine the cerebral activity patterns, as assessed by fMRI in human volunteers during the withdrawal from chronic cocaine administration and the ability of several cognitive tasks to activate the brain at a function of time of withdrawal and drug craving.